Robot-Assisted Personalized Prostate Biopsy

PROJECT SUMMARY/ABSTRACT
Prostate cancer (PCa) is the most commonly diagnosed type of cancer and the second leading cause of cancer
related death among US men. The best current estimate of PCa aggressiveness is the Gleason score obtained
from core biopsy. The most common biopsy method is freehand transrectal ultrasound (TRUS) guided. Since
ultrasound only rarely identifies PCa visually, systematic biopsy (SB) intends to sample the prostate evenly. But
freehand SB is highly inconsistent, subjective, and results in uneven sampling, leaving large regions of the
prostate unsampled, which can lead to under-sampling of clinically significant cancer and under-staging of PCa
diagnosis at biopsy.
The current trend in prostate biopsy is directed towards a targeted biopsy (TB) approach guided by
multiparametric Magnetic Resonance Imaging (mpMRI). Several advanced biopsy devices are available and
register (fuse) the mpMRI to interventional ultrasound. TB yield a higher significant PCa detection rate than SB.
But SB on patients with no mpMRI findings found many men to harbor PCa, so SB is currently performed in addition
to TB. However, SB use the same 12-core extended sextant plan for all patients regardless of their gland shape.
Moreover, significant variability exists among urologists at freehand biopsy, even with the fusion devices.
Our team has developed and tested the feasibility of a novel robotic device that takes SB from a one-
size-fits-all to a patient-optimized plan, and from a freehand to a hands-free skill-independent robot-
assisted procedure. No similar devices currently exist. This technology consists of a robotic ultrasound probe
manipulator and software for ultrasound processing, robot control, fusion TB, and optimized SB planning. Our
novel SB planning software optimizes the biopsy core locations for each patient to maximize the likelihood
of detecting clinically significant PCa and taking into account mpMRI visible lesions, if available.
The robotic device was cleared for clinical trials by the Food and Drug Administration and our Institutional Review
Board approved the study. A Phase 0, Safety and Feasibility clinical trial was successfully completed. We
propose a Phase I clinical trial to gain early evidence on the effectiveness of personalized biopsy planning and
precision biopsy to improve the detection rate of clinically significant PCa in a randomized clinical trial versus
one of the most common fusion biopsy devices on the market.
The specific aims of the 5-year project are: A1) Perform randomized clinical trial of robot vs. the fusion device.
Include patients with mpMRI exams. On each arm, perform SB on PI-RADS≤2 and TB+SB on PI-RADS≥3
patients; A2) Record pathology from subset of patients of A1 who proceed to radical prostatectomy, and compare
biopsy to prostatectomy results on both arms; A3) Offline, simulate SB alone plans for patients who undergo
SB+TB and determine if SB cores could overlap TB locations;

Public health relevance
PROJECT NARRATIVE Current systematic prostate biopsies use a one-size-fits-all biopsy plan that is still being used even in conjunction with modern MRI-guided fusion biopsy devices, and the biopsy remains freehanded making the results variable among urologists. We have developed novel software that optimizes the biopsy plan for each patient and a robot that handles the ultrasound probe and automatically orients the needle-guide to follow the plan, making the biopsy procedure hands-free and independent of physician’s skills. We have successfully completed a safety and feasibility clinical trial, and propose a larger randomized clinical trial to investigate if our robot increases the detection rate of clinically significant prostate cancer relative to that of a modern commercial biopsy device.